Task A53: High Throughput Evaluation of COVID-19 Therapeutics in Small Animal Models

This contract provides for the development and standardization of small animal models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure